HMGB1 acetylation as differentiating biodosimeter of lethal versus sub-lethal radiation

There are currently no approved biodosimeters that can differentiate between lethal (>5 Gy) and sub-lethal (>5 Gy) total body irradiation. This work will test the hypothesis that high amounts of acetylated HMGB1 are released early after exposure to lethal doses of ionizing radiation, and that release of HMGB1 and site-specific lysine acetylation correlates with the reversibility and severity of organ damage.